Mechanisms of Hematopoietic Stem Cell and Blood aging

PROJECT DESCRIPTION
The hallmarks of the aging blood system, such as chronic inflammatory disorders, anemia,
immunosenescence and hematological malignancies, result in large part from hematopoietic stem cell (HSC)
dysfunction. Age-associated loss of HSC function is linked to metabolic deregulation, increased dependence on
autophagy, loss of epigenetic fidelity, replication stress-associated genomic instability, and chronic exposure to
local inflammation in the aged bone marrow (BM) niche microenvironment. However, these remain largely
descriptive features of HSC aging. This project aims to develop a coherent and mechanistic model of how these
extrinsic signals and intrinsic molecular mediators promote old HSC dysfunction, ultimately suggesting
actionable targets for rejuvenation interventions. In Aim 1, we will test the hypothesis that autophagy
engagement is a prosurvival stress-response mechanism that protects a subset of old HSCs from chronic
inflammation in the aged BM niche. Specifically, we will probe whether increased oxidative metabolism in old
HSCs functions to compensate for decreased glucose utilization due to chronic inflammation-induced insulin
resistance. Insulin resistance is increasingly appreciated to affect non-canonical tissues, such as the brain,
where it has been connected to age-associated inflammation and neurodegeneration. We will establish how the
inflamed marrow milieu directly promotes insulin/IGF-1 pathway resistance, how this drives autophagy
engagement and metabolic adaptation in a subset of old HSCs, and whether old HSC regenerative potential can
be improved through fasting/refeeding interventions via normalization of insulin sensitivity and glucose uptake.
In Aim 2, we will further dissect how replication stress contributes to the functional exhaustion of aged HSCs. In
particular, we will focus on the fragile ribosomal DNA (rDNA) loci, which are severely impacted by replication
stress in old HSCs, interfering with ribosome biogenesis. Defects in ribosome biogenesis lead to an accumulation
of free ribosomal proteins triggering activation of a p53-dependent nucleolar stress response, as well as defects
in protein translation, whose stringent regulation is critical for maintaining HSC functionality. We will explore the
interplay between replication and nucleolar stress, investigate the intrinsic and extrinsic mechanisms surrounding
decreased ribosomal biogenesis and impaired proteostasis, and identify the cellular programs responsible for
the onset of replication stress in old HSCs to design functional rejuvenation interventions. This work has exciting
implications for elucidating the biology of HSC aging at molecular resolution and identifying actionable targets
for promoting HSC functional longevity, a logical strategy for restoring blood and immune cell production in the
elderly.

Public health relevance
PROJECT NARRATIVE Although many insights into the biology of aging have been gained, which underscore the multifactorial nature of this process and its complex regulation by interconnected genetic and environmental factors, we still know comparatively little about the mechanisms by which aging alters stem cell function and the organismal consequences of age-related stem cell exhaustion. The goal of this project is to develop a comprehensive model of maladapted stress-response mechanisms in aged hematopoietic stem cells (HSC) to identify actionable targets for rejuvenation interventions. In particular, we will leverage our identified hallmarks of an old HSC state to determine whether manipulating autophagy levels or mitigating the harmful effects of replication stress can restore the functional fitness of aged HSCs.